MAGNITUDE AND MECHANISMS OF EXERCISE CONDITIONING IN OLDER CORONARY PATIENTS

The goal of this project is to determine the magnitude and mechanism of the exercise conditioning response in older (>62 yrs) coronary patients in resp se to an aerobic training program.